Rho Federal Systems Division, Inc. NIAID DAIT SACCC

This project is a one-year extension of the consolidated DAIT Statistical and Clinical Coordinating Center
(DAIT SACCC). The extension will enable crucial continuity of services while the individual successor
contracts assuming the work of the DAIT SACCC are awarded and any necessary transitions occur. The
DAIT SACCC supports research in the areas of asthma and allergic diseases, autoimmune diseases, and
transplantation. The objective of the DAIT SACCC is to provide efficient coordination of the following
services: protocol development, study initiation and management, statistical design and analysis, clinical
site monitoring, ancillary services, data management, and safety oversight. During the extension, the DAIT
SACCC will continue to (1) provide staff experienced in research conducted by DAIT-supported consortia
and organize these staff in an administrative structure that manages resources efficiently, is responsive to
the needs of the research consortia and DAIT, and facilitates communication and collaboration; (2) provide
experienced scientists and statisticians who, in collaboration with clinical investigators and DAIT officials,
design and analyze studies across the full scope of research; (3) facilitate the development, review, and
revision of protocols and protocol-related documents through dedicated protocol teams; (4) provide study
initiation and study management functions required for the efficient, valid, and ethical conduct of studies;
(5) provide well-developed procedures and personnel for the monitoring of clinical sites; (6) provide efficient
and accurate tracking and reconciliation of specimen collection and distribution; (7) provide integrated and
secure information management systems and procedures for the collection of clinical and mechanistic data;
(8) help ensure patient safety by providing high-quality serious adverse event (SAE) reporting and Data
and Safety Monitoring Board (DSMB) reports; and (9) provide tools, infrastructure, and analytical support in
the planning, implementation, analysis, and dissemination of high dimensional mechanistic studies.

Public health relevance
This project is a one-year extension of a coordinating center that provides investigators with expertise, tools, and support to conduct effective clinical research studies in the areas of allergy, immunology, and transplantation. Services include the design of the studies, the capture of necessary data, the management of all the clinical sites, the oversight of potential safety issues, and the analysis of the data providing results. By continuing to support investigators as they conduct successful research studies, the public gains a better understanding of the mechanisms of these disease areas that yields improved health for patients.